Integrative single cell analyses of inflammation-derived circulating hybrid cells to identify aggressive disease

PROJECT SUMMARY
The lifetime risk for acquiring colorectal cancer (CRC) is 7%, with an astounding rate of disease recurrence in
32% of newly diagnosed patients after their “successful” treatment. Patient with recurrent disease have a dismal
14.3% five-year survival. Lack of effective biomarkers hampers early detection of pre-metastatic disease,
impacting overall survival from CRC. We identified a promising disseminated tumor cell—a product of
macrophage (MФ) and cancer cell fusion—that harbors genotypic and phenotypic features of both cells of origin.
Detectable along the metastatic cascade, hybrid cells can initiate tumor growth, migrate in response to MФ
receptor-ligand chemotaxis, and seed metastatic sites. In peripheral blood, hybrids, named circulating hybrid
cells (CHCs) outnumber conventionally defined circulating tumor cells (CTCs) in CRC patients, overcoming the
sensitivity of CTC—a primary barrier—to usage as a biomarker for disease. CHCs are phenotypically diverse
and reflect protein expression of the primary tumor. Based on these exciting findings, we propose that hybrid
cells subpopulations harbor discrete phenotypes of pre-metastatic cells that can be identified and defined using
single cell image-based phenotyping through multiplexed imaging and multimodal integration with –omics. To
this end, we will analyze CHCs derived from early stage and metastatic tumors for image-based phenotyping
with single cell gene expression. Utilizing quantitative and advanced image analytics including deep learning
approach for image-based cell profiling, we will define inter/subcellular spatial features in single cells to identify
new subpopulations and differentiate discrete phenotypic populations associated with metastatic signatures. In
addition, the application of both imaging and genomic technologies to the same specimen independently
measures highly dimensional, yet non-orthogonal, sets of cellular features. Multimodal integration of imaging
and single cell data will quantify systems-level biological functions of cellular subpopulation and enhance imaging
biomarker panel to gain biomarker specificity and sensitivity for validation in a discrete CRC patient cohort. Our
overall goal is to develop a novel tumor biomarker, based upon CHC phenotyping and –omics analyses that can
be used to provide new quantitative insights and develop machine-driven prediction with superior accuracy for
identifying risk of metastases in CRC patients to ultimately impact survival.

Public health relevance
PROJECT NARRATIVE Despite advances in screening, colorectal cancer remains a leading cause of cancer-related death due to a high recurrence rate after initial treatment and a dismal 14.3% survival rate of patients with recurrent disease. Improving survival from colorectal cancer requires the ability to develop effective biomarkers for early detection of recurrent/pre-metastatic disease. We leverage computational approaches to integrate imaging and –omics analyses to establish and validate a non-invasive biomarker for risk of metastases.